Effects of Early and Prolonged Parent-Child Separation: Understanding Mental Health among Separated-Reunited Chinese American Children

PROJECT SUMMARY/ABSTRACT
The goal of this K99/R00 proposal is to facilitate Dr. Shaobing Su's transition into the role of independent
investigator focused on understanding how early and prolonged parent-child separation (i.e., separated at ages
0-6 for at least 6 months per year) shapes the mental health of separated-reunited children in the United States
(US). This proposal builds on Dr. Su's strong foundation in quantitative and intervention research through a risk
and resilience lens and her prior research on mental health and development of vulnerable children, especially
children born to immigrants or migrants. Dr. Su seeks to expand her knowledge of the literature related to child
development and parent-child separation as well as her repertoire of methodological skills, including cultural
adaptation of theories, measures, and interventions for racial and ethnic minorities, qualitative and mixed-
method research, Community Based Participatory Research (CBPR) approaches, and grant writing.
This CBPR-based exploratory sequential mixed-methods research comprises 3 aims and 3 studies:
Study 1 (Aim 1) will elucidate the mental health challenges that arise in Chinese American children with a
history of early and prolonged parent-child separation; and identify potential processes that might influence
mental health. Study 1 involves semi-structured interviews with Chinese separated-reunited children (N=48,
aged 12-17) and their parents (N=48 primary caregiver parents).
Study 2 (Aim 2) will examine mental health disparities and risks and resources between separated-reunited
children and non-separated children; and explore the relationships among separation, risk, and protective
factors at multiple levels, and affected children's mental health outcomes. Study 2 is a quantitative study
among 200 Chinese American separated-reunited children and 200 non-separated children (aged 12-17).
Study 3 (Aim 3) will identify focal areas and potential “active ingredients” to prioritize as components for
development of a targeted intervention for affected children and families. Study 3 will use mixed-methods
analyses to integrate qualitative (Study 1, Community Advisory Board recorded discussions) and quantitative
findings (Study 2, Boston College seed grant) to seek convergence and divergence as the basis for a model of
change and integrate it into existing family strengthening models for mental health interventions.
The CBPR-based, mixed-methods research may deepen understanding of the impact of parent-child
separation on child development and effects of multilevel risk and protective factors. Findings may inform
intervention, policy, and practices for separated-reunited Chinese American children as well as other children
affected by other forms of separation (e.g., children in institutional settings, children separated at the border).
This award will support Dr. Su's transition to independent research in parent-child separation and mental
health; and enable her to develop R01 proposals to adapt and evaluate family-strengthening interventions for
affected children or to expand the research to other child cohorts with a longitudinal sequential design.

Public health relevance
NARRATIVE Early and prolonged parent-child separation due to parental migration or immigration may result in attachment disruption that can threaten the long-term mental health and functioning of affected children, and these risks can persist following reunification and through adulthood. Although sending infants back to the home country for rearing is often practiced among Chinese immigrants, especially low-income families, research has been sparse in understanding the long-term impact of early and prolonged parent-child separation and reunification on disparities in mental health and functioning among separated-reunited children and the mechanism through which such relationships may operate. The proposed exploratory sequential mixed-methods research comprises 3 studies—(1) qualitative interviews with affected children and parents, (2) a quantitative survey, and (3) mixed-methods analysis—to understand the mental health impacts, risk/protective factors, and service needs among separated-reunited Chinese American children.